Adoption and Implementation of an Evidence-based Safe Driving Program for High-Risk Teen Drivers

PROJECT SUMMARY
Motor vehicle collisions (MVCs) are the leading cause of death among teens in the United States. Teen drivers who
have committed a traffic violation are at an even higher risk of MVC-related injuries and deaths compared to their
counterparts without a traffic violation. While parent engagement interventions are an effective strategy to improve
driving safety among teens of all risk profiles, these interventions have not been translated and tested among high-
risk teen drivers such as those with a traffic violation. Furthermore, to date, no studies have examined the cost-
effectiveness of interventions that promote safe teen driving practices. This proposed study addresses princi-
pal gaps in teen driving research by translating an evidence-based universal intervention to a high-risk, yet un-
derstudied, population of teen drivers with a traffic violation. This study will test, in a hybrid randomized controlled
trial (RCT), the implementation, effectiveness and cost-effectiveness of the new intervention, Steering Teens Safe+
(STS+) that integrates in-vehicle driving feedback technology with parent communication training. Our long-
term goal is to inform juvenile traffic courts’ adoption and implementation of evidence-based, cost-effective in-
terventions into high-risk driving populations, and reduce MVCs and MVC-related injuries and deaths. Our
three specific aims are: Aim 1: Determine if both intervention groups are superior to and more cost-effective than
the control group on the outcomes of parent-teen communication, teens’ risky driving behaviors, traffic violation re-
cidivism, and MVCs. Aim 2: Examine differences in intervention outcomes and cost-effectiveness by mode of deliv-
ery (expert- vs. peer-delivered intervention). Aim 3: Identify the contextual factors associated with adoption and im-
plementation of the intervention. We will recruit 290 parent-teen dyads from rural and urban juvenile traffic courts in
Ohio following their mandatory court hearing. Each dyad will be comprised of a teen driver (ages 16 to 17) who has
committed a moving violation and a parent/legal guardian. Enrolled dyads will be randomly assigned to 1 of 3 study
groups: 1) Expert-delivered intervention, 2) Peer-delivered intervention, and 3) Control. Our central hypothesis
is that the peer-delivered intervention is non-inferior (i.e., not much worse) to and more cost-effective than the ex-
pert-delivered intervention and that both intervention groups are superior to the control. This project is significant
because it represents a substantial step forward in national research focused on teen drivers, an area in which
implementation research has been underrepresented. This study is innovative because it will recruit high-risk teen
drivers through a unique partnership with rural and urban traffic courts, utilize cutting-edge in-vehicle driving feed-
back technology, and test the mode of intervention delivery. The findings will facilitate the widespread adoption,
implementation, and dissemination of STS+ in rural and urban settings and will have an impact on juvenile traf-
fic courts’ practices and policies aimed to improve teen driving safety by reducing MVCs and MVC-related injuries
and deaths.

Public health relevance
PROJECT NARRATIVE Parent-engagement strategies, while effective in reducing teen motor vehicle collisions (MVCs), have not been implemented and tested among high-risk teen drivers such as those with a traffic violation. Through established collaborations with rural and urban juvenile traffic courts in Ohio, this study will test, in a hybrid randomized controlled trial, the implementation, effectiveness, and cost-effectiveness of a parent- engagement intervention tailored to the needs of teen drivers with a traffic violation. The findings will have an impact on juvenile traffic courts’ practices and policies aimed to improve teen driving safety by reducing MVCs and MVC-related injuries and deaths, which aligns with NICHD’s ongoing research priority.